Computation, Bioinformatics, and Statistics (CBIOS) Training Program

PROJECT SUMMARY
The Penn State ‘Computation, Bioinformatics, and Statistics (CBIOS) Predoctoral Training Program’ will train a
new generation of scientists with strong computational, statistical, biological, and science communication skills
to enable them to develop and lead interdisciplinary collaborative research efforts that promote advances in the
biomedical and life sciences. The goals of CBIOS are consistent with the ‘Bioinformatics and Computational
Biology’ program at National Institute of General Medicine. The aim is to train a new class of scientists with a
primary identity as computational biologists/bioinformaticians, and whose disciplinary core draws from an
emerging set of principles on how to compute, analyze, and apply biological data. The goals of the first five
years of the CBIOS program were to train students “that can think statistically, use computational and statistical
tools, and generate computational and statistical innovation to keep pace with the quickly evolving landscape of
high-throughput genomics technologies.” The second cycle of CBIOS will continue to provide a strong foundation
in quantitative and life sciences, and incorporate a new science communication curriculum aimed at developing
fluency in communicating the purpose, significance, and outcomes of research to diverse stakeholders in the
science, medicine, policy, and business arenas. CBIOS builds upon six established graduate programs including
four departmental and two intercollegiate programs. Training faculty participating in the program belong to five
different colleges and two campuses – providing a broad and interdisciplinary research spectrum. Most of the
training faculty are affiliated with the intercollegiate Bioinformatics and Genomics graduate program and belong
to centers of excellence under the auspices of the Genome Sciences Institute, which provides a common
platform for interactions. Our faculty interact closely – as evidenced by joint authorship on research publications,
co-funded grants, co-teaching, and co-advising of graduate students. They have a combined annual research
funding base of $75,265,600 direct cost, offering a solid foundation for trainees’ research experience and
opportunities. Combining NIH and Penn State support, CBIOS plans to train a minimum of 18 predoctoral
trainees over a period of five years. Each trainee will be supported for two years (year 2 and 3 of their graduate
career) while receiving a foundational curriculum through the CBIOS program. Trainees will gain a thorough
understanding of the scientific process, responsible conduct of research, fluency in research methodologies,
ability to utilize computational, bioinformatics and statistical tools in large-scale genomic data analysis,
excellence in communication to diverse audiences, leadership in cross-disciplinary research teams, and
excellent professional developmental activities. After the two years of support, trainees will continue to participate
in monthly trainee meetings and remain connected with program activities throughout their graduate career.

Public health relevance
PROJECT NARRATIVE The exploration of large, high dimensional data on genomes, transcriptomes, proteomes, and metabolomes is providing critical information linking myriad of inter-individual differences, or inter-cellular differences within individuals, to health or diseases. Analysis and interpretation of the comprehensive datasets generated by contemporary genomics research requires skills cutting across the disciplines of computer science, bioinformatics, statistics and the biological sciences. Our predoctoral training program prepares a cadre of young scientists to excel in cross-disciplinary skills encompassing computation, statistics, biology and science communication, and to be innovative leaders in a research community that strives to harvest insights from ‘omics’ data to improve human health.